DETERMINANTS OF SELF-RENEWAL, DIFFERENTIATION, AND REPROGRAMMING OF HESCS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Objective: The goals of project 3, led by Dr. Slukvin, are to identify genes and epigenetic modifications most critical for reprogramming fibroblasts and blood cells to pluripotent state. This project uses WNRPC Stem Cell Resources. Publication: Hu K, Yu J, Suknuntha K, Tian S, Montgomery K, Choi KD, Stewart R, Thomson JA, Slukvin II. Efficient generation of transgene-free induced pluripotent stem cells from normal and neoplastic bone marrow and cord blood mononuclear cells. Blood. 2011 Feb 4. PMID: 21296996